Glucoregulatory Hormone Interactions in Diabetes

Project Summary/Abstract
Hypoglycemia and its adverse effects on brain function remain the major factor limiting the use of intensified
insulin therapy that has been shown to prevent or delay the long-term complications in type 1 diabetes (T1DM).
Higher cognitive functions (e.g. working memory) that involve the prefrontal cortex are particularly sensitive to
neuroglycopenia. This proposal seeks continued support of a long-term RO-1 grant with the long-term goal of
documenting the health benefits of insulin delivery strategies that minimize the risk of frequent bouts of
hypoglycemia in T1DM patients. The specific aims of the current project outlined below use functional
magnetic resonance imaging (fMRI) and magnetic resonance spectroscopy (MRS) techniques to assess the
changes in brain function and fuel metabolism caused by acute hypoglycemia and acute hyperglycemia in
T1DM patients with hypoglycemia unawareness (versus hypoglycemia-aware T1DM patients and healthy
controls) as well as the potential beneficial impact of employing closed-loop insulin delivery systems to improve
brain function in hypoglycemia unaware T1DM individuals. The protocols rely heavily on human investigation
involving non-diabetic as well as hypoglycemia aware and unaware T1DM subjects exposed to experimental
mild and moderate hypoglycemia and acute hyperglycemia using the glucose clamp technique while
undergoing brain imaging. However, we also take advantage of the power of rodent diabetic models to test
specific mechanistic hypotheses. The primary hypothesis of this proposal is that hypoglycemia unaware T1DM
patients not only have impaired hormonal and symptomatic responses, but also lack another key hypoglycemia
defense mechanism, namely the capacity of the brain to activate motivation/reward circuits due to adaptive
increases in brain glucose transport and metabolism as well as stimulation of the polyol pathway. The specific
aims are to determine: 1) If T1DM patients with hypoglycemia unawareness (vs. T1DM and non-diabetic
controls) lose the capacity to elicit brain responses to visual food cues as well as functional connectivity in
striatal and a variety of other brain regions in response to food cues during mild and moderate hypoglycemia
using the glucose clamp technique; 2) If patients with T1DM and hypoglycemia unawareness display adaptive
changes causing excessive increases in brain glucose transport and metabolism in response to acute
hyperglycemia that induce adverse neurocognitive effects within the pre-frontal cortex, a key brain region for
cognitive function not previously examined in humans using magnetic resonance spectroscopy (MRS). In
addition, mechanistic studies will be conducted in diabetic rats exposed to recurrent hypoglycemia to define the
molecular mechanisms driving the changes in brain fuel metabolism induced by intensive insulin treatment;
and 3) if reducing glycemic variability with a closed loop insulin delivery system in patients with hypoglycemia
unawareness can reverse alterations in brain glucose transport/metabolism as well as functional connectivity,
thereby reverse brain dysfunction induced by current intensive T1DM insulin treatment.

Public health relevance
Project Narrative: The benefits of intensified insulin therapy in type 1 diabetes (T1DM) are limited by higher rates of severe hypoglycemia, often occurring without warning symptoms and as a result, many patients do not achieve target glycemic goals due to comcommitant hyperglycemia since their immediate fear of hypoglycemia exceeds their fear of long-term complications. Therefore, understanding the pathophysiological mechanisms driving brain changes leading to hypoglycemia unawareness and the impact of hyperglycemia in those hypoglycemia unaware T1DM patients is essential for preventing brain injury. Furthermore, it needs to be determined whether these adverse brain metabolic changes can be reversed by closed loop artificial pancreas treatment.